2020 Biology of Acute Respiratory Infection Gordon Research Conference and Gordon Research Seminar

Abstract Respiratory infections are a leading cause of morbidity and mortality worldwide. The measles outbreak and continued increase of antibiotic resistant bacterial infections are stark reminders of the urgent public health risks of these infections. The purpose of this proposal is to provide funds to support travel support for invited speakers and young scientists to present and attend the 2020 Gordon Research Conference (GRC) Biology of Acute Respiratory Infection, which will be held in Galveston, Texas February 16-21, 2020. This conference will bring together groups of scientists, from basic to applied, public health officials and clinicians that normally do not attend the same meetings to highlight new findings and concepts in respiratory tract infections including, disease in vulnerable populations, intrinsic, innate and adaptive immune responses, infection-mediated exacerbations in individuals with lung diseases, the future for respiratory vaccines and exciting new models and tools. It will be especially important to encourage a new generation of young scientists to not only study respiratory infections, but to build networks allowing them to take a “wholistic” approach to research. Although there are a few meetings dedicated to specific respiratory microbes or systems, this is the only meeting focused on bringing a diverse community together and encouraging young investigator participation making it unique.

Public health relevance
Respiratory infections are a leading cause of morbidity and mortality worldwide. Yet, our understanding of the biology and treatment of acute respiratory infections, especially in high risk populations, is incomplete. The goal of the 2020 Gordon Research Conference (GRC) Biology of Acute Respiratory Infection is to fill this gap in knowledge by bringing together groups of junior and senior scientists, public health officials and clinicians that normally do not attend the same meetings, to highlight new findings and concepts in respiratory tract infections.